Community Health and Neuropathy: Nutritional and Environmental Links in Zambia (CHANNELZ)

Project Summary/Abstract
The overarching goals of this project are to advance knowledge of the complex pathophysiology of distal
symmetric polyneuropathies (DSP) and frame future interventions for nutritional neuropathies in Zambia
through: 1) assessment of population-based estimates and risk factors for DSP in Zambia’s maize and
cassava staple food zones; 2) comparison of population-based estimates and risk factors to previous clinic-
based data from the same maize-staple districts; 3) and assessing the odds of specific micronutrient
deficiencies among DSP cases and age, gender, and HIV-matched controls from the same districts. To
accomplish these goals, Dr. Kvalsund will focus on acquisition of additional expertise and experience in the
following key areas: 1) advanced epidemiological methods and analysis; 2) clinical trials methodologies, 3)
global health policy; 4) neuropathy outcome assessments; and 5) HIV and nutrition. The needed skills will be
achieved through structured mentorship, coursework, and pragmatic clinical trials and health policy
experiences. The research-training plan will provide Dr. Kvalsund with the additional proficiency necessary to
undertake future intervention research aimed at reducing nutrition-associated neurologic morbidity in Zambia
and advancing scientific knowledge of the pathophysiologic mechanisms that generate DSP as a common
phenotype. The central hypothesis is that the high rate of DSP previously observed in clinic populations in
Zambia is equally prevalent outside healthcare settings owing to common endemic infectious diseases and
their neurotoxic treatments, food insecurity and low dietary diversity, recurrent nutritional challenges, specific
micronutrient deficiencies and their interactions, and possibly other unidentified latent factors. We hypothesize
that folate-deficiency will be highly associated with DSP in Zambian communities, as has been documented in
clinic populations, and may warrant a targeted public health intervention given the preventable nature and
range of other neurologic morbidities also associated with folate deficiencies. The specific aims are to: 1)
Determine population-based DSP estimates in Zambia; 2) Compare and contrast DSP estimates and risk
factors with those from clinical settings in Zambia; 3) to consider the relative contributions of urbanicity,
agroecological/staple food zone, and specific micronutrient deficiencies on DSP prevalence; and 4) Evaluate
for latent environmental or toxico-dietary factors as contributors to DSP in this environment. The research is
expected to provide the foundation for future R-01 intervention and observational research and to improve
scientific understanding of how diverse etiologies, multiple exposures and interactions lead to a common
clinicopathologic DSP phenotype, which remains poorly understood to date.

Public health relevance
Project Narrative Distal Symmetric Polyneuropathies (DSP) are highly prevalent among clinic populations in Zambia compared to other world regions and preventable nutritional and other treatable comorbidities are suspected to be contributing. Our study is designed to identify clinic- versus population-based risk factors for DSP in this setting. These studies will help define appropriate intervention targets for nutrition-associated neurologic morbidity in Zambia and frame future observational studies to identify complex pathogenic mechanisms involved in asymptomatic and symptomatic DSP development.